Bacteriophage strategies to lyse bacterial cells

Project Summary
Bacteriophage, or phage, infect and kill bacterial cells. At a programmed time, phage use a tailored suite of
proteins to release newly built virions by lysing the host cell. As the most common cell lysis event on the planet,
phage-induced lysis drives both microbial biogeochemical nutrient cycling and population dynamics in cellular
life. Host cell lysis in tailed phages is an active process carried out by phage proteins that specifically target
each cell envelope layer. In Gram-negative bacteria, phage holin proteins compromise the inner membrane,
endolysins degrade the peptidoglycan, and spanins disrupt the outer membrane. Molecular studies in a few
classic systems, such as phages T4 and lambda, exposed common functional principles governing lysis.
However, striking differences in their mechanisms of action also taught us about bacterial envelope layers and
their regulation. In addition, bacteria often co-opt phage lysis proteins to accomplish diverse behaviors
beneficial to a population such as seeding biofilm establishment and releasing toxins. Therefore, studying novel
phage lysis proteins will advance our understanding of both phage and fundamental principles in their hosts.
Further, we and others have demonstrated that identifying or predicting the function of novel lysis proteins
based on sequence analysis alone is ineffective. Therefore, the studies proposed here focus on experimental
characterization of novel phage lysis protein mechanisms. For example, in E. coli phage Mu, where
bioinformatics predicted a canonical lysis pathway, we demonstrated that Mu lyses cells using a protein of
unknown mechanism in place of a holin. In a second example, we showed that E. coli phage phiKT produces an
antimicrobial peptide-like protein instead of spanins to disrupt the outer membrane, akin to eukaryotic
antimicrobial peptides. Finally, we have identified for study lysis protein candidates that are significantly
different from known proteins in phages infecting abundant and understudied human gut microbiota.
Our goals for the next five years center on in-depth molecular characterization of two specific novel lysis
proteins and diverse candidates from less-studied phages infecting gut microbiota. We will use genetic,
biochemical, and microscopy approaches to elucidate mechanisms of individual proteins. Direct competition
assays will probe the contributions of lysis proteins to phage persistence and fitness, characteristics that drive
environmental microbial population composition. Overall, these projects are expected to uncover divergent
mechanisms of action used by phage in E. coli model systems and other prevalent gut microbiota. Broadly, this
foundation can be leveraged to study lysis protein types active across many different bacteria, which is critical
to understanding global microbial population fitness and turnover. The new molecular strategies uncovered
here may lead to more efficacious medical treatments since lysis is also the basis of successful phage therapy,
which aspires to use phages as alternative treatments for antibiotic-resistant bacterial infections.

Public health relevance
Project Narrative The proposed research aims to understand the diversity of strategies used by the natural predators of bacteria, the bacteriophages, to kill their host targets. By studying how phage kill bacteria in depth, we can formulate new strategies to eliminate problematic pathogens that cause human disease. Thus, this proposal supports the NIGMS mission to fund research laying the foundation for advances in human disease treatment and prevention.